Collaborative Microbial Metabolite Center

Project Summary/Abstract
The interaction between our diet, metabolism by the microbiome, and the downstream biological effects
on the host are key foundational knowledge that will guide the development of precision medicine integrated
with nutrition. To characterize the function of these individual metabolites that are transformed from foods or
fully synthesized by the microbiome will improve the mechanistic understanding of Microbe-Diet-Host
interactions. Despite this importance, the community lacks a knowledge management center that centralizes
and aggregates bioactivity and function of these metabolites that hinders the ability of researchers to reuse
knowledge in a high throughput fashion and build off the discoveries of others. The proposed “Collaborative
Microbial Metabolite Center” or CMMC proposed here will fill this void in the scientific landscape, aiming to
integrate microbial metabolite discovery and activity from PAR-21-253 grantees and the broader microbial
metabolomics community. The CMMC will build a centralized microbial metabolites bioactivity knowledge base
that aims to work with the grantees and community to define standards to represent bioactivity, handle
community depositions of knowledge and supporting raw data, aggregate depositions into corroborated
knowledge, apply knowledge to new data, propagate knowledge into previous uncharacterized molecules, and
integrate with other community knowledgebases that host complementary knowledge for microbial metabolites.
All data, knowledge, and tools will be made findable, accessible, interoperable, and reusable (FAIR).
This proposal will 1) Build the web portal for microbial metabolites with search, export, and analysis
functions. 2) Build a microbial metabolite knowledgebase with the accompanying R01 grantees, NIDDK, and the
larger scientific community. 3) Coordinate data sharing activities, training and technical support and organize a
yearly meeting.
The PIs and Co-Is are well suited to address the needs and build the proposed knowledge base, due to
their expertise in microbial metabolomics (Dorrestein), microbiome (Dorrestein, Knight), knowledge base
creation (Dorrestein, Wang, Knight, Bandeira), community outreach (Dorrestein, Wang), platform training
(Dorrestein, Wang), community tool integration (Wang), community knowledgebase integration (Dorrestein,
Wang, Knight, Bandeira), scalable tool development (Wang, Bandeira), and data resiliency (Wang, Bandeira).

Public health relevance
Project Narrative Understanding the interaction between the foods we eat, metabolism by our microbiome, and the downstream effect on our bodies is key to deepening our understanding of nutrition. However, the scientific community lacks a centralized resource to collectively aggregate discoveries, hindering the ability to build on others' works. By building a knowledge base together with the needs of the community, we aim to aggregate, propagate, and apply this community knowledge that will serve to accelerate new discoveries.